Investigation of the role of VEGFA in harnessing cholangiocyte-driven liver regeneration

PROJECT SUMMARY / ABSTRACT
Liver disease affects hundreds of millions of people worldwide. Liver transplantation remains the only treatment
for end stage liver disease (ESLD); however, transplantation faces a major burden due to a shortage of liver
donors. The liver is known for a remarkable regenerative ability through hepatocyte-driven regeneration, the
proliferation of the main functional liver cell type, the hepatocyte. However, in ESLD, hepatocyte proliferation
becomes exhausted. An alternative strategy to treat ESLD would be to promote liver regeneration through biliary
epithelial cell (BEC)-driven regeneration as a novel mechanism that could be exploited as a therapeutic target.
BEC-driven liver regeneration is a process by which BECs proliferate, transition to a liver progenitor cell (LPC)
stage, a process defined as ductular reaction (DR), and differentiate into functional hepatocytes and restore liver
function. BEC-driven regeneration has been experimentally demonstrated in mouse models in which hepatocyte
proliferation was compromised and in our zebrafish models after near complete ablation of hepatocytes.
Observation of DR in virtually all chronic and acute human liver diseases and of budding hepatocytes from BECs
in human cirrhotic livers suggests that BEC-driven repair occurs in human, yet differentiation into hepatocytes is
insufficient to alleviate the liver disease. Our goal is therefore to identify and test a druggable pathway that
triggers BEC-to-hepatocyte conversion for the efficient therapeutic use of BECs to treat liver diseases. We
propose that VEGFA promotes BEC-to-hepatocyte conversion and rescues liver function in complementary
mouse and zebrafish liver injury models. Our preliminary data demonstrate that delivery of VEGFA in injured
mouse livers via the non-integrative and safe nucleoside-modified mRNA complexed with lipid nanoparticles
(mRNA-LNP) induces robust BEC-to-hepatocyte conversion and reversion of steatosis and fibrosis. Moreover,
blocking VEGFR2, the main receptor for VEGFA, or downstream mediators PI3K/AKT abrogates BEC-driven
liver regeneration in zebrafish, suggesting the key contribution of the VEGFR2/PI3K/AKT axis. Previous studies
showed that VEGFA promotes liver repair in rodents by stimulating VEGFR2 on endothelial cells (ECs) that
induce the secretion of hepatocyte mitogens and thus drives hepatocyte-driven repair. However, it has not been
reported that VEGFA directly affects BECs for BEC-driven repair, which is suggested by our preliminary data
showing VEGFR2 induction in a subset of BECs in injured mouse livers, an observation also reported by others
in injured rats. Therefore, our findings combined with studies from others lead us to test 2 hypotheses using the
complementary mouse and zebrafish liver injury models: (Aim 1) VEGFA delivery in vivo triggers BEC-to-
hepatocyte conversion to replenish the lost cell mass and restore liver functions, and that (Aim 2) VEGFA acts
directly on BECs and/or indirectly on ECs that express VEGFR2. This study may have key clinical significance
by establishing a treatment to prevent progression of the liver disease, by exploiting the alternative intrinsic
regenerative ability of the liver via BEC-driven liver regeneration using clinically safe mRNA-LNPs.

Public health relevance
PROJECT NARRATIVE The liver is known for a remarkable regenerative ability through the proliferation of the main functional cell type of the liver, the hepatocyte; however, in end stage liver disease (ESLD), hepatocyte proliferation is exhausted. To overcome the scarcity of donor livers for transplantation to treat ESLD, promotion of the liver’s own biliary epithelial cell (BEC)-mediated regeneration could provide a pool of functional hepatocytes that replenish the liver, thereby recovering liver function. The proposed research is relevant to public health and the NIH mission, as it will establish new therapeutic interventions to promote generation of functional hepatocytes derived from BECs with VEGFA delivered in the liver via clinically safe non-integrative nucleoside-modified mRNAs complexed to lipid nanoparticles.